Administrative Core – Improving Provider Announcement Communication Training (IMPACT)

ABSTRACT – Administrative Core
The Administrative Core will provide overall guidance, administrative support, and fiscal management for
the P01 Program Project, “Improving Provider Announcement Communication Training (IMPACT).” Dr. Noel
Brewer will be the Administrative Core Lead as well as the Principal Investigator for the Overall Program
Project. The Administrative Core will have a central function in establishing linkages and integration between
all program elements, ensuring regular communication both within the program and with external
organizations, and overseeing the Program Project as a whole and the pilot grant program. The three specific
aims of the Administrative Core are as follows. Aim 1. Foster effective collaboration across IMPACT's
research projects and cores to achieve integration of their research activities and products. The
Administrative Core will establish an Integration Committee comprised of project and core leads; annually
convene the External Advisory Board comprised of stakeholders including vaccination providers and
healthcare system leaders; and coordinate our Annual Scientific Retreat. Aim 2. Manage IMPACT's
operations and progress toward milestones. The Administrative Core will provide organizational leadership
and infrastructure necessary for overseeing research projects and shared core resources; provide
administrative support to ensure regulatory compliance of research; oversee fiscal management and reporting;
and monitor projects' and cores' progress toward milestones across all phases of research. Aim 3. Administer
the Rapid Response Pilot Grant Program. The Pilot Grant Program will fund new and timely pilot studies to
address emerging ideas and the evolving needs of the field. Using a comprehensive approach, the
Administrative Core will leverage our integrated research projects and cores, collaborative relationships,
shared resources, and investigators' expertise to establish capacity that individual research projects could not
achieve on their own. The Administrative Core addresses the IMPACT Program Project theme by helping our
research projects to build capacity for HPV vaccine communication interventions among primary care teams in
healthcare systems.

Public health relevance
NARRATIVE – Administrative Core Not applicable.